Interaction of Nutrient & Organochlorine Absorption

DESCRIPTION (provided by applicant): Organochlorine compounds (OCs) are toxic, carcinogenic, and ubiquitous in the environment. Oral ingestion is the principal route of entry into the human body for many OCs. Because of the lipophilicity of OCs and many of their metabolites, they are preferentially stored in adipose tissue, but are also found in liver, brain, and other organs and tissues. Although oral ingestion is the initial step in the accumulation of OCs in animals and humans, the processes involved in absorption from the intestine and early transport in blood and lymph are not well characterized. We propose studies that will shed light on these important steps in absorption and transport to provide a basic framework that can lead to understanding the ways that nutrients influence the absorption processes. In Specific Aim 1, we will determine the mode of absorption and association of OCs with carriers in lymph and the portal blood and whether this is affected by the amount and the type of lipid fed. We demonstrated that labeled hexachlorobenzene (HCB) carried in chylomicrons is cleared from the circulation faster than the labeled fatty acid (FA) as part of the triglyceride (TG). To explain this finding, the labeled HCB must not have been dissolved in the TG lipid core of the chylomicron. If it is, then its rate of removal from the circulation should be slower or at best equal to that of the labeled TG. Consequently, in Specific Aim 2, we will determine the mode of delivery of labeled OCs to the tissues (especially the adipose tissue) by proteins, phospholipids, and chylomicrons (CMs). We will also determine the partitioning of HCBs between chylomicrons and any membranes it comes in contact with e.g., red blood cell membrane. Lastly, in Specific Aim 3, we will determine if the relative importance of vehicle (albumin, lipid, or lipoprotein) carrying the labeled OC in blood is altered as a result of weight loss or weight gain (i.e. changes in body fat). The proposed research is important because of the biological and clinical importance of OCs in health and disease and they provide considerable new insights into how OCs are carried and delivered to the various organs in the body.